Detection of pathogen infection by monitoring host cell membrane dynamics

PROJECT SUMMARY
Innate recognition of pathogenic bacteria involves sensing both the physical presence of potentially harmful
microbes and the perturbations of host physiology that accompany infection. By monitoring for the effects of
pathogen infection on the host rather than for the infectious microorganism itself, surveillance immunity
enables the host to direct immune defenses towards bona fide pathogens during an infection and not harmless
commensal bacteria. The concept of surveillance immunity was first described in plants and in the nematode
C. elegans, and subsequently, a few specific examples have been characterized in mammals. However, it is
unknown how pathogen-induced changes in host physiology activate immune defenses.
Here, we advance a new hypothesis of innate immune sensing that stems from the concept of surveillance
immunity. The central hypothesis of this proposal is that pathogen infection causes a change in the fluidity of
intestinal plasma membranes, which is sensed by the host to induce innate immune defenses. Specifically, we
propose that pathogen infection alters fatty acid desaturation in the phospholipid compartment of plasma
membranes, which reduces their fluidity and leads to activation of intracellular immune signaling cascades.
Through genetic studies of host-pathogen interactions in the nematode C. elegans, we made several
observations that provide the rationale for this idea: (i) Membrane fluidity dynamics are monitored to activate
innate immune defenses. Disruption of a transcriptional regulator of fatty acid biogenesis and desaturation
decreases membrane fluidity and causes immune activation in a manner that recapitulates intestinal infection
by bacterial pathogens. (ii) The p38 PMK-1 innate immune pathway, a host defense pathway of nematodes, is
activated in C. elegans mutants that have membrane fluidity pathology. (iii) Pathogen infection rapidly depletes
host fatty acids and suppresses the transcription of genes that synthesize monounsaturated fatty acids.
Importantly, we found that pathogen infection also disrupts the fluidity of intestinal epithelial cell plasma
membranes. (iv) Finally, cell membrane fluidity is required for pathogen resistance. C. elegans mutants with
defects in membrane fluidity are hypersusceptible to pathogen infection, and restoration of membrane fluidity
dynamics complements this mutant phenotype.
In this proposal, we will characterize host surveillance of intestinal cell plasma membrane fluidity as a novel
mechanism to activate innate immunity (Aim 1). We will also define the pathogen-induced changes in
membrane composition that decrease plasma membrane fluidity (Aim 2) and determine the mechanism of p38
PMK-1 pathway activation during bacterial infection (Aim 3). The proposed study will define a general strategy
employed by C. elegans to detect pathogen-induced disturbances in host physiology, revealing fundamental
insights into a previously unrecognized, evolutionarily ancient strategy of immune activation.

Public health relevance
PROJECT NARRATIVE Bacterial infections cause numerous changes to our cells, which underlies the morbidity and mortality from infectious diseases. We will determine how our immune system detects these cellular changes to activate anti- pathogen defenses. These findings will characterize a new mechanism of pathogen detection that will substantially advance the field of innate immunity and have broad implications for the study of immune activation.